CORE FUNCTION ACTIVITIES TASK ORDER FOR ADVISORY SERVICES AND ADMINISTRATIVE REPORTING. TASK ORDER NUMBER 75N94021D00016 75N94021F00001 ADMINISTRATIVELY REPLACES TASK ORDER NUMBER 75N94021D00009 75N9

CORE FUNCTION ACTIVITIES TASK ORDER FOR ADVISORY SERVICES AND ADMINISTRATIVE REPORTING.